Gene Expression Profiling On Insulin Resistance And Obesity

We are performing global exon expression profiling to complement the ongoing positional cloning effort to identify susceptibility genes for diabetes and its predictors, insulin resistance, insulin secertory dysfunction and obesity. To this end, we are examining exon expression profiles in tissue samples from non-diabetic full-blooded Pima Indians using Affymetrix exon arrys that query over 1 million known and predicted exons across the entire genome.[unreadable] We have collected 225 skeletal muscle tissue samples and 300 adipose tissue samples[unreadable] from non-diabetic Pima Indians who have been metabolically phenotyped for body composition and insulin action in vivo using the hyperinsulinemic euglycemic clamp. Follow up data is available on the diabtic status of most of these volunteers, up to 7-10 years later, so will be able to identify a prediabtic exon expression profile in this population. In the past year we have completed the exon arrays on all skeletal muscle samples and have extracted the RNA from the adipose samples and these are ready for analysis.